Translational Neuroimaging & Neurophysiology Core

PROJECT SUMMARY
Both new investigators with an interest in testing IDD-related hypotheses and experienced investigators
who may wish to expand their research portfolios to address important IDD-related issues often find that there
are structural barriers to entry into a new research path. High costs of modern imaging techniques, the
specialized technical aspects of experimental design, data acquisition and analysis, as well as working with
new patient populations can each constrain execution of important translational research. The purpose of the
Translational Neurophysiology and Neuroimaging Core (TNN) is to provide access to a set of modern (if
complex) tools, access to the professional expertise so that use of these tools can be productive, and access
to an intellectual environment that encourages and supports new and ongoing research on IDDs. To
accomplish these important goals, the TNN has a set of aims that include providing UR-IDDRC members
access to human and small animal neuroimaging tools (3T and 9.4T MRI), human and small animal
electroencephalography (EEG), Mobile Brain/Body Imaging, and access to pilot funding to defray the costs of
using these tools to jump-start new IDD research. TNN faculty and staff will consult with investigators on the
design of the experiment, assist with the implementation of protocols and train investigators and/or their
trainees (postdocs and students) to perform the data processing and analyses. A monthly users group meeting
also allows new investigators to learn about current protocols, capabilities and ongoing projects that might
synergize with their own proposed work, and to develop collaborative relationships with other TNN
investigators.
In addition to this general support for UR-IDDRC members, the TNN core also supports the proposed
research project “Bridging the translational divide from cells to patients: toward reliable neuro-markers
of Batten disease.” Aim 1 of the research project proposes to investigate auditory processing in children with
Juvenile Neuronal Ceroid Lipofuscinosis in an effort to construct a neurophysiological biomarker of disease
progression. Aim 2 of the research project proposes develop an identical EEG-based neuromarkers in murine
models of Batten disease. The TNN serves as the hub for murine model EEG and also human EEG in people
with and without IDDs. The facilities and services described in this core will be key elements to successful
completion of the Aims of the research project.